Defining the Mechanism of Complement Pathway Activation during Pregnancy and its Role in Adverse Pregnancy Outcomes in Sickle Cell Disease

PROJECT SUMMARY/ABSTRACT
The complement system and its careful regulation play critical dual roles in maintaining healthy pregnancy –
combating infection and allowing tolerance of the semi-allogenic fetus. The trigger of complement activation and
pathway(s) involved in pregnancy remain elusive. Complement dysregulation or excess activation is implicated
in pregnancy loss, preterm birth, and development of pre-eclampsia and the HELLP syndrome. Sickle cell
disease (SCD) is a thromboinflammatory disorder with high rates of adverse pregnancy outcomes (APOs),
including severe pre-eclampsia, preterm birth, fetal growth restriction, and fetal loss. Complement activation is
implicated in SCD-related organ damage, though the role of complement in SCD pregnancies has not been
explored. In the US, maternal mortality in women with SCD is ~10 times higher than in black pregnant people
without SCD, highlighting the need for translational studies to address these pathobiologic mechanisms. Dr.
Gerber has initiated prospective collection of serial blood samples and clinical data during pregnancy in SCD
and generated exciting preliminary data suggesting that classical complement is triggered by IgM in pregnancy.
This proposal employs the bioluminescent modified Ham (bmHam), a novel, functional assay of membrane-
directed complement activation that has the ability to test specific complement pathways using targeted
inhibitors. We will prospectively collect serial samples from healthy pregnant women (controls) and women with
HbSS disease during pregnancy. We will define the pathway and triggers of increased complement activity in
controls and pregnant women with HbSS disease. Using the bmHam, we will compare differences in complement
activity by trimesters between pregnant women with HbSS disease and controls. We also will test the association
between increased complement activity and the development of APOs in women with HbSS disease. Lastly, we
will evaluate the influence of SCD genotype (e.g., HbSS, HbSC) on complement activity in non-pregnant women
of reproductive age to determine expansion of our pregnancy cohort. Elucidating the role of complement
activation as a mechanism and biomarker for APOs in SCD pregnancies will provide a tool for risk stratification
and potentially early intervention strategies to be tested in future clinical trials.
This mentored research and career develop award will facilitate Dr. Gerber’s long-term goal of becoming a
translational investigator in classical hematology with a focus on thromboinflammatory disorders during
pregnancy. Dr. Gerber’s interdisciplinary team of mentors and advisors have extensive expertise in complement-
mediated disorders, bioassay development and translational research methods, reproductive health in SCD,
maternal fetal medicine, placental biology, and biostatistics. The additional proposed experiential and didactic
training in reproductive research methods, longitudinal cohort analysis, prospective cohort study design and
biomarker testing, and clinical trial design will enable her to transition to an independent investigator at the
intersection of hematology and women’s health bridging clinical and laboratory researchers.

Public health relevance
PROJECT NARRATIVE Women with sickle cell disease, a common inherited blood disorder that can affect nearly every organ system in the body, have high rates of pregnancy complications like preeclampsia (high blood pressure and protein in the urine), premature birth, and even death of the mother or baby. We will study the role of complement, a group of proteins that are part of the immune system and closely linked to inflammation and clotting pathways, in causing these pregnancy complications. We will use what we learn from this study to better identify how pregnancy complications happen in women with sickle cell disease, so we can predict who may get these complications and then study targeted treatments to improve outcomes for mothers and their babies.